Orexin Receptor Antagonists as Modulators of Threat Sensitivity in individuals with Alcohol Use Disorder

ABSTRACT
Alcohol use disorder affects millions and is one of the leading causes of preventable death worldwide. In the US,
pharmacotherapy for AUD is under-utilized; related to the fact that there are only three FDA-approved drugs to
treat patients with AUD. These medications work well for some but have small to moderate effect sizes on
drinking outcomes. The development of more efficacious pharmacotherapies for AUD is a top public health
priority. A recent emphasis in psychiatric medication development is the use of reliable human laboratory
measures of AUD dysfunction to test promising compounds to directly inform and power large-scale mechanistic
clinical trials. PI Gorka and Co-I Phan have developed an assay of stress reactivity that is robustly related to
drinking behavior and AUD. This assay reflects a negative reinforcement model of AUD and is reliably captured
in the lab using complimentary objective psychophysiological (i.e., startle eyeblink potentiation) and
functional neuroimaging measures. Using this model, we have uncovered that suvorexant (SUV) – a dual
receptor antagonist of the orexin system, FDA-approved for insomnia – acutely modifies our AUD target in
healthy adults, while sparing changes in other markers of stress reactivity. Compelling animal and human
evidence together suggests that the orexin system is critically involved in stress-related alcohol use. The
overarching goal of this R21 proposal is to systematically advance this line of work to uncover if, how, and for
whom orexin antagonism modifies brain-behavior stress targets of AUD to inform and power future large scale
clinical trials. The study is a targeted double-blind, between-subjects, randomized clinical trial design with repeat
lab assessment. A total of eighty subjects with AUD will complete our psychophysiological stress paradigm at
baseline. They will return to the lab days later to repeat the protocol following administration of a single dose of
either 10mg SUV or placebo (40 subjects/arm). Participants are then instructed to take daily 10mg capsules of
SUV or placebo for the next 4-weeks before returning for a post-treatment lab assessment. Daily reports of
medication adherence, side-effects, sleep, alcohol use, and mood will be collected via smartphones. This study
is high-risk, high-reward, and to match the scope of the R21 mechanism we will focus on startle eyeblink
potentiation as the primary outcome; although a subset of 20 subjects per arm (40 total) will also complete our
stress task during simultaneous startle and functional magnetic resonance imaging (fMRI), pre- and post-
treatment. This innovative multimodal design allows for a well-controlled test of whether an acute dose of SUV
(Aim 1) and/or daily use of SUV (Aim 2) modifies brain-behavior targets of AUD dysfunction, particularly within
individuals with high objective baseline stress reactivity. We will also examine whether daily SUV changes
alcohol behavior, and whether this change in behavior is linked to brain-behavior change (Aim 3). Findings from
this study will provide critical new knowledge regarding if and how orexin antagonism can be leveraged to treat
AUD. The findings will also be used to inform and power a large-scale mechanistic clinical trial of SUV for AUD.

Public health relevance
PROJECT NARRATIVE Alcohol use disorder (AUD) is a debilitating disease for which very few effective pharmacological treatments exist. To accelerate the pace of AUD drug discovery and bring forth mechanistic treatment options, researchers are urged to test promising preclinical compounds using valid and reliable human laboratory measures of AUD pathophysiology. Compelling and convergent evidence suggests that the neural orexin system is critically involved in stress-related alcohol use and therefore, the goal of the current study is to uncover if, how, and for whom an orexin system antagonist (i.e., suvorexant) modifies well-defined brain-behavior targets of AUD dysfunction to inform and power large-scale mechanistic clinical trials.